Single-cell multiomic methods for studying genome structure and function

PROJECT SUMMARY
The three-dimensional (3D) genome organization in the nucleus is pivotal to various genome functions such
transcription and DNA replication. Recent development in both genomic and imaging-based technologies has
drastically advanced our understanding of the multiscale 3D genome structures and their variability in single
cells. However, although methods can separately map transcriptome (e.g., single-cell RNA-seq) or 3D genome
(e.g., single-cell Hi-C), no technology exists to map both 3D genome and transcriptome in the same cells,
significantly limiting the investigation of the relationship between genome structure and function at the single-cell
level. For example, without such a co-assayed method, it remains infeasible to study how 3D genome
architecture functionally informs spatiotemporal transcriptional rewiring in single cells in developmental
processes. To fill this major gap in the field of single-cell epigenomics, this project will develop new technologies
for quantitatively comparing 3D genome and gene expression in the same single cells. We will develop CARE-
seq, a novel single-cell multiomic solution, coupled by our state-of-the-art computational tools, to unveil the
connections between 3D genome organization and gene expression as well as their spatial and temporal
variations. (1) We will develop the first co-assayed method to jointly measure whole-genome chromatin
interactions and gene expression in the same single cells from complex tissues in a massively parallel manner.
(2) We will develop a new method to concurrently profile single-cell transcriptome and specific promoter-
enhancer loops in thousands of individual cells. (3) We will further combine spatial biology with our single-cell
method to develop a spatially resolved approach for deciphering in situ dynamics of both 3D genome and gene
expression in single-cell resolution for tissues. Collectively, the new technologies developed in this project will
provide unprecedented new opportunities to systematically understand the interplay between 3D genome
structure and transcriptional regulation for a wide range of biological contexts.

Public health relevance
PROJECT NARRATIVE 3D genome organization plays important roles in human health and disease. Profiling both 3D genome and gene expression in the same single cells opens an unprecedented opportunity to understand the interplay between transcriptional and epigenetic mechanisms driving cells during development and pathogenesis. This project is relevant to public health because it proposes to develop novel tools for studying genome structure and function.